DIETARY FAT MODULATION OF ANDROGEN (ESTROGEN) METABOLISM IN MEN

To study the effects of decreasing fat and increasing fiber in the diet on the levels of male sex hormones in blood, urine and prostate of men.